5HT modulation of arousal and chemoreflex responses in intact and SCI mice.

Sleep apnea is associated with autonomic, cardiovascular, metabolic and cognitive co‐morbidities. The
incidence of sleep apnea in the United States ranges from 2‐4 % in the general population, and is up to 15 times
greater in individuals with spinal cord injury (SCI). Adjustments in the neural modulation of the arousal
threshold (AT), chemoreflex sensitivity to hypoxia and hypercapnia (CS) and upper airway patency are three
critical factors that contribute to exacerbation of sleep apnea. The exact neuromodulators that control these
variables are enigmatic, but one possibility is serotonin (5HT) and its target receptors. Thus, plasticity of 5HT
neurons may account for modifications in the AT, CS, upper airway patency and ultimately breathing stability
in intact and spinal cord injured (SCI) animals. We will explore the role of 5HT in modulating the critical
factors that exacerbate sleep apnea in intact and SCI mice. Aim 1 of our proposal will examine the impact of
5HT on the AT and CS to ultimately determine the impact on sleep disordered breathing. Aim 2 will explore
whether modifications in 5HT levels and/or receptor sub‐types following SCI, are coupled to modifications in
the AT and CS leading to hypoventilation, blunting of upper airway muscle function and increases in the
frequency and duration of apnea events. Aim 3 will determine whether modifications in 5HT levels and/or
receptor sub‐types following SCI, are coupled to increases in upper airway collapsibility. To explore these
relationships unanesthetized, spontaneously breathing intact and SCI tryptophan hydroxylase 2 knockout
(TPH2‐/‐) and wild type (TPH2+/+) mice will be employed. The absence of TPH2 results in the depletion of
central nervous system 5HT, while the raphe neurons remain intact. We will measure ventilatory parameters,
the AT and CS before and after SCI in TPH2+/+ and TPH2‐/‐ mice. Breathing events will be detected during sleep
via electroencephalograms. Apneic events will be uncovered by monitoring ventilation and diaphragmatic
electromyography, while monitoring of genioglossus muscle activity will be used to detect modifications in
upper airway muscle function before and after SCI. Our results will establish if modifications in 5HT
modulation, either via genetic depletion or SCI, leads to alterations in the AT, CS, upper airway muscle
function and ultimately breathing stability.

Public health relevance
Sleep disordered breathing is associated with a number of health problems. The incidence of sleep disordered breathing is increased significantly in individuals with spinal cord injury. However, the reasons for this increase are unknown. The increase may be related to a blunting of the arousal and ventilation response to decreases in oxygen levels and increases in carbon dioxide levels because of changes to serotonin neurons following spinal cord injury. Our study will explore these possibilities using a non‐anesthetized spontaneously breathing mouse model with or without genetic depletion of central nervous system serotonin, before and after spinal cord injury.